Core--Genotyping

The Genotyping Core will provide sample preparation and genotyping for both Project by Israni and Project by Jacobson. DNA will be extracted from whole blood received from all seven clinical cores. In phase 1,1,000 samples will be analyzed using a custom SNP chip. Identified candidate SNPs will then be further analyzed using a combination of high throughput and moderate throughput methodologies. The Core will have the flexibility of including additional SNPs for analysis and they become identified, either through subsequent analysis, or through the literature. The genotyping core will be responsible for: Phase 1 1) DNA extraction 2) Custom SNP chip genotyping Phase 2 3) Preparing samples for high throughput SNP genotyping 4) Genotyping SNPs for Project by Israni and Project by Jacobson.